Integrative Omics Center for Accelerating Neurobiological Understanding of Opioid Addiction (ICAN)

PROJECT SUMMARY/ABSTRACT
The overarching goal of the Integrative Omics Center for Accelerating Neurobiological Understanding of
Opioid Addiction (ICAN) is to identify biologically actionable drivers of opioid addiction (OA). We will (1)
conduct large-scale integrated multi-omics studies of OA in humans, (2) integrate rodent–human studies to
identify genes and gene networks implicated in OA, and (3) build a publicly available national omics resource
for studying OA. Our cohering principle is that by integrating multiple omics across human and animal model
data we will discover robust drivers of individual variation that predispose opioid users to addiction.
The omics revolution has delivered many discoveries of such individual variation for complex diseases,
including for nicotine and alcohol phenotypes, but not for OA. We see five fundamental challenges to rapid
progress: (1) limited sample sizes and unaccounted-for phenotypic heterogeneity in genome-wide
association studies (GWAS) of OA; (2) very limited human brain studies of gene dysregulation by OA; (3)
poor translation between human and animal model studies; (4) lack of concurrent integration of multiple
omics; and (5) limited practical access to, and poor harmonization of, OA omics data.
To overcome these challenges, ICAN harnesses four Projects and two Cores:
Project 1: Electronic Health Record Phenotyping and Genomics of Opioid Addiction
Project 2: Gene Regulation in the Opioid Dependent Human Brain
Project 3: Multi-species Approach to Opioid Addiction
Project 4: Multi-omics Gene Network Identification
Cores: Administrative Core and Synergy Core
Across these Projects and Cores, we will (1) conduct the largest GWAS to date (N>100,000 cases)
leveraging Genomic Structural Equation Modeling; (2) examine differential gene regulation across key brain
regions (prefrontal cortex, nucleus accumbens, amygdala) in the largest collection of OA informative
postmortem brains to date (N=641); (3) integrate rodent and human studies using GeneWeaver.org,
polygenic transcriptome risk scores, and variant functionalizing experiments; and (4) apply explainable
artificial intelligence, gene network mapping, and multiple lines-of-evidence integration for gene network
discovery. Each Project is rigorously designed to make novel contributions. However, by integrating the
diversity of ICAN’s science through the cross-fertilization and coordinating efforts of the Cores, we will
leverage the agnostic discovery power of omics and place it within the context of functional neurobiology to
make field-changing breakthroughs and identify actionable targets for development of OA treatments.

Public health relevance
PROJECT NARRATIVE Opioid addiction (OA) is a deadly public health burden in the United States and across the globe, and it continues to worsen, with more than 70,000 U.S. deaths in 2020—the highest on record. In spite of 30 years of research, we still do not have a clear understanding of why some people are more likely to become addicted than others, although we do know that a person’s genes are strongly related. Our proposed Integrative Omics Center for Accelerating Neurobiological Understanding of Opioid Addiction (ICAN) will coordinate a team of top genomics researchers from multiple institutions to conduct four interlocking studies that will put tools in the hands of researchers countrywide to make field-changing breakthroughs, which ultimately, will improve options for treating opioid addiction.